ACTG 362--EFFICACY OF AZITHROMYCIN PROPHYLAXIS FOR PREVENTION OF MAC DISEASES

This study will compare the time to development of MAC disease in subjects receiving azithromycin to those receiving placebo among subjects who have had an increase in their CD+ count from below 50 to above 100.